In vivo regulation of cell trafficking and the extracellular matrix

SUMMARY. We use C. elegans to study membrane trafficking and its impact on development and the apical
extracellular matrix (aEMC) that surrounds the epidermis. Our work with collaborators centers on two conserved
“pathways”, which until recently had been largely overlooked by the membrane trafficking field. Theme 1. We
found that conserved NIMA-related kinases NEKL-2/NEK8/9 and NEKL-3/NEK6/7 regulate membrane trafficking
and actin dynamics in worms and mammals. Theme 2. We found that membrane-associated SYM-3/FAM102A
and SYM-4/WDR44 bind to trafficking factors and likely mediate the transport of bulk lipids at membrane contact
sites (MCSs) via the lipid transferase BLTP-2/BLTP2. Both pathways ultimately impact the epidermal aEMC: loss
of NEKLs causes defective molting, a cyclic form of aECM (cuticle) remodeling, whereas loss of SYMs leads to
mechanical deformation of the embryo due to defects in the pre-cuticle. Many central questions remain regarding
the mechanisms by which NEKLs and SYMs carry out their conserved functions. Theme 1 questions include: (i)
How does loss of NEKLs/NEKs alter membrane trafficking and actin dynamics? (ii) What are the functions of
nekl genetic suppressors and how do they alleviate nekl defects? (iii) How do proteins identified by NEKL–MLT
BioID studies physically and functionally interact with NEKLs? (iv) What are the substrates of NEKLs/NEKs and
how are they regulated by phosphorylation? Theme 2 questions include: (i) Which MCSs are bridged by the
SYMs and BLTP-2? (ii) What roles do the SYMs play in localizing BLTP-2 to MCSs? (iii) What proteins act with
the SYMs and BLTP-2 to mediate lipid transport? (iv) How does perturbation of the SYMs and BLTP-2 affect
membrane lipid composition and trafficking? We address these questions through molecular, genetic, cell
biological, proteomic, modeling, and biochemical approaches and complementary studies in C. elegans and
mammalian cell culture to broaden the impact of our work. Collectively, these studies will lead to new mechanistic
insights into the functions of conserved but largely uncharacterized regulators of membrane trafficking implicated
in cancers, ciliopathies, and neurological disorders. Theme 3. We use the C. elegans syncytial epidermis as a
model to understand how cell fusion affects nuclear functions and tissue differentiation. Our findings indicate that
fusion is necessary for the normal transition from embryonic to larval development including the production of
larval cuticle components. Syncytia are found throughout the animal kingdom in both healthy and diseased
tissues, but little is known about the effects of syncytialization on subsumed nuclei. Theme 3 questions include:
(i) How does syncytium formation impact nuclear transcriptomes and tissue differentiation? (ii) Are syncytial
nuclei heterogenous (specialized) or homogenous? (iii) How are nuclear identities maintained or modified foll
fusion? We will address these questions using genetics; omics methods, including snRNAseq; and cell biological
analysis with smFISH methods and transcriptional reporters. These studies will expand our knowledge of the
roles and properties of multinucleate syncytia, including a role in aECM assembly, which are largely unexplored.

Public health relevance
Narrative: For cells to be viable and work cooperatively with other cells within an organism, they must routinely move proteins and lipids between various internal compartments, as well as from the inside to the outside of the cell and vice versa. This internal–external exchange of proteins and lipids is essential for building and remodeling the extracellular matrix, a highly complex protein-based network that surrounds all cells, providing structural support and affecting nearly all aspects of cell function. We study this cellular transport system and its impact on the extracellular matrix to understand fundamental aspects of cell and developmental biology and because defects in this conserved process lead to human disease including physiological and neurological disorders and cancer.